Periodic Contrast-Enhanced CT With HYPR Reconstruction For Ablation Monitoring

DESCRIPTION (provided by applicant): Monitoring ablation growth and determining treatment efficacy has become one of the most significant challenges facing thermal tumor ablation. Post-ablation imaging provides no way to monitor the ablation as it develops and current real time strategies fail to provide sufficient spatial resolution of the ablation zone. Without a means to monitor ablation growth, there is no way to prevent unintended thermal damage before it occurs, nor is it possible to alter the course of treatment at the most effective times. In this application, we will begin to develop, optimize and validate a new treatment monitoring technique using technology already available on most scanners using periodic contrast-enhanced computed- tomography (CECT). Periodic CECT will allow monitoring at several time points during the course of treatment while minimizing the total contrast load to the patient. Specifically, we propose to: 1. Measure the uptake and transport of contrast media during thermal ablation Here we will measure the retention or expulsion of contrast media in normal liver and kidney, and two tumor models during ablation. 2. Optimize administration of contrast media and image acquisition parameters for ablation monitoring with periodic CECT In this aim we will characterize periodic CECT during thermal ablation and optimize scan timing, radiation dose and contrast infusion rate using simplex methods. 3. Automate HYPR processing for periodic CECT ablation monitoring. This aim will focus on developing applicator discovery, block matching and registration algorithms to facilitate automated HYPR processing during each imaging sequence. 4. Validate the periodic CECT technique with histopathology and standard CECT In this aim the validity of periodic CECT will be verified by comparing the imaging appearance and histopathology of ablations created in normal liver and kidney, and two tumor models.

Public health relevance
PROJECT NARRATIVE This proposal addresses one of the most challenging aspects of tumor ablation today: adequate procedure monitoring. Using periodic contrast-enhanced CT and HYPR reconstruction, we plan to create and optimize a simple ablation monitoring technique that makes use of common technology in every imaging center, minimizes radiation and contrast dose, and provides high-quality images for periodic ablation monitoring and improved assessment of treatment success. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The overall goal of this application is to develop and validate a new imaging modality to monitor tumor ablation treatments. Thermal ablation is now becoming a first-line treatment option for many patients with liver, kidney and bone tumors due to the low morbidity, fast recovery and similar efficacy of ablative procedures when compared to surgical resection. With recent technological improvements in energy delivery, the use of ablation is expanding into new organs (eg, lung, breast), larger tumors, and more challenging locations. However, ablation treatment monitoring techniques have not kept pace with device development. The lack of effective treatment monitoring has become the single-most important factor limiting wider adoption of minimally invasive ablation. Current real time monitoring techniques include tracking bubble formation on CT or ultrasound, monitoring temperatures on the applicator, MR thermometry and ablating for a pre-determined time. These techniques are either too crude to provide accurate feedback, or rarely used outside of large academic centers. We hypothesize that an effective intra-procedural treatment monitoring technique would provide the physician sufficient information to: 1. Reposition or add new applicators, adjust power inputs, and define treatment endpoints based on imaging feedback. Imaging data, when proven as a reliable surrogate for tissue pathology, would be far more useful than the applicator temperature or time endpoints used currently. 2. Avoid complications caused by inadvertent heating of vulnerable tissues surrounding the ablation zone (eg, bowel, bile ducts, diaphragm, ureters). Complications are often not discovered until post- procedure imaging or symptoms develop, and can be fatal. In addition, physicians often treat tumors near critical structures less aggressively, which increases the possibility of recurrence. Contrast-enhanced CT (CECT) is the dominant diagnostic, guidance and follow-up imaging modality for thermal ablation in the United States due to its high spatial resolution and excellent contrast between ablated and normal tissues, so would be a logical choice for ablation monitoring. However, 1) iodinated contrast administration is typically limited by patient tolerance to less than 2 ml/kg or 150 ml - enough for one post-ablation exam; and 2) performing multiple diagnostic scans increases radiation dose to the patient and physician. A CECT ablation monitoring technique that is highly accurate in depicting the ablation zone while heating, limits contrast load to less than 150 ml, and keeps accumulated radiation dose below the level of an abdominal CT would represent a significant advance in medical care. HighlY constrained back PRojection (HYPR) reconstruction can be used to enhance features that changed between temporal imaging frames and has been shown to improve image quality sufficiently so that contrast load or radiation dose may be reduced by up to 100x when compared to conventional imaging. Thus, we hypothesize that dose reductions provided by HYPR will enable the use of periodic CECT to create a highly accurate, ablation treatment monitoring technique. To test this hypothesis, we propose the following specific aims: 1. Measure the uptake and transport of contrast media during thermal ablation It is currently unknown how iodinated contrast media reacts to pressure and temperature-induced transport caused by thermal ablation, which is important for periodic CECT imaging. Here we will measure the retention or expulsion of contrast media during ablation in normal and malignant tissues. 2. Optimize administration of contrast media and image acquisition parameters for ablation monitoring with periodic CECT Contrast uptake can be tracked and the ablation volume imaged using simple tools already integrated into modern CT systems. In this aim we will characterize periodic CECT during thermal ablation and optimize scan timing, radiation dose and contrast infusion rate using simplex methods. 3. Automate HYPR processing for periodic CECT ablation monitoring This aim will focus on developing applicator discovery, block matching and registration algorithms to facilitate automated HYPR processing during each imaging sequence. 4. Validate the periodic CECT technique with histopathology and standard CECT In this aim the validity of periodic CECT will be verified by comparing the imaging appearance and histopathology of ablations created in in vivo porcine liver, woodchuck HCC and rabbit VX-2 tumors. The successful completion of this proposal would create a clinically relevant tool for monitoring ablation treatment that could be deployed rapidly for widespread use. An effective tool for ablation monitoring that improves safety and confidence in the procedure could also increase adoption of ablative techniques by lowering the barrier to entry for new practitioners.